Genetics and Pathobiology of Cutaneous Mosaic Disorders

PROJECT SUMMARY:
Cutaneous mosaic disorders are severe, rare genetic skin disorders appearing in patterns due
to somatic mutation during embryonic development. The timing of mutation determines the
identity and extent of affected tissue and the risk of systemic disease. We have found that
consequences of such mutations can be severe as in rapidly-growing, treatment-unresponsive
congenital hemangiomas due to GNA14 mutation, or severe osteomalacia in the cutaneous-
skeletal hypophosphatemia syndrome due to multi-lineage somatic activating RAS mutations. A
broad collaborative network of physicians and scientists have enabled our work to gain new
insight into skin biology through genetic discoveries in cutaneous mosaic disorders. In the last
funding period, we identified three new genes for cutaneous mosaic disorders, provided
evidence for phenotypic expansion in six others, and proved efficacy of a novel pathogenesis-
directed therapy for porokeratosis now commonly used in dermatology care. We now propose a
more comprehensive and rigorous approach to cutaneous mosaic disorders we have found less
frequently have mutations in known genes and represent a greater opportunity for discovery.
These include mosaic inflammatory disorders which are localized, severe manifestations of
common inflammatory disorders such as atopic dermatitis and psoriasis, hamartomatous
mosaic disorders, vascular anomalies, and atypical presentations of epidermal nevi. We screen
for mutations in potential causative genes, and employ an integrated multiomics approach to
discover novel genetic causes and gain biological insight into disease pathogenesis. We will
utilize patient-derived cells and tissue to interrogate the function of novel genes, and will employ
organotypic tissue to study and prove pathogenesis of identified mutations. For a limited
number of compelling, novel genes previously unrecognized to be relevant to skin biology, we
will employ CRISPR-generated mouse models to study disease pathobiology. These studies will
continue to identify molecular pathways central to the complex processes of epidermal
differentiation, self-renewal, and inflammation, and will provide critical context for future biologic
studies and development of novel therapeutics.

Public health relevance
PROJECT NARRATIVE: The study of genetic skin disorders, including patterned skin conditions known as mosaic disorders, has identified many pathways important for normal skin function. We propose to employ comprehensive genetic evaluation to identify additional genetic causes of these disorders and to gain insight into mechanisms of skin disease. This work will benefit public health, as gaining insight into genetic causes of these diseases will provide new information about how the skin maintains and renews itself and about cutaneous inflammation with implication for generation of new targeted therapies for common skin disease.